Image-based cerebrovascular network snythesis(iCNS) to model Alzheimer's Disease

Significant resources on age-related neurodegeneration are directed toward animal research in the
assumption that results will inform our understanding of parallel processes in human. Yet, no reliable method
exists to accurately translate cerebral blood flow or metabolic data from animal to human. For lack of rigorous
mathematical methods for cerebral metabolic parameters between species, translation of valuable research data
from mouse to human remains guesswork. There is a need for a predictive computational framework that
quantifies cerebral blood flow and metabolism in normal and diseased human brain states. Our long term goal
is to quantify fundamental physiological processes of aging and Alzheimer’s disease (AD), so that their effects
can be slowed or even partially reversed. The objective is to expand the utility of MRI analysis by magnifying the
detectability of age-related microcirculatory changes in humans with a mechanistic mathematical framework. It
is our hypothesis that age and AD related changes in the microcirculation also generate macroscopic
perturbations of hemodynamic and/or oxygen perfusion states that will be detectable with advanced MRI
techniques, when guided by rigorous brain simulations over all relevant length scales. The rationale is that critical
physiological metrics for dysfunction in aged brains (=aging biomarkers) will be exposed by systematic
exploration and simulation of fundamental hemodynamic and metabolic processes. The central hypothesis will
be tested by pursuing three specific aims:
Aim 1) Assess the predictive value of mechanistic modeling by simulating the link between capillary stalling,
vascular tracer transit properties, and tissue oxygen delivery, and validate predictions using advanced
microscopic imaging in mouse. We determine the effects of aging and AD in aged rodent brains.
Aim 2) Develop mechanistic multiscale model for predicting the impact of cerebral perfusion on oxygen
metabolism in the human cortex under normal and pathological conditions. Anatomically detailed mechanistic
models of cerebral circulation in human will predict the effect of structural and functional changes in AD on
oxygen extraction in the human brain with MRI.
Aim 3) Assess the predictive value of mechanistic multiscale modeling to quantify microvascular properties
across the human brain cortex in health and disease using advanced MRI. To validate the mechanistic translation
from mouse to human, we will measure age-related metabolic functions in cohorts of aged and Alzheimer
patients. We identify hemodynamic and metabolic metrics (=biomarkers) that correlate with cognitive decline
This contribution is significant because it will predict how changes in vascular morphometry and metabolism
lead to neurological decline. It will identify biomarkers visible in noninvasive diagnostic imaging in humans that
signal age-related deterioration before symptoms develop. The mechanistic framework relating data acquired in
mouse to human will dramatically boost the relevance of animal data for human medicine.

Public health relevance
NARRATIVE The project will quantify both healthy and deteriorated cerebral metabolic function in order to precisely correlate biological conditions with age and Alzheimer-related decline. As the main thrust, a computational framework, fully validated by advanced imaging at the cellular level, will be created for translating research data acquired in animal models to human. This computational platform will remove the guesswork from the interpretation of findings obtained in mouse as they relate to aging in humans, ultimately leading to the ability to accurately monitor, diagnose, and treat metabolic disorders causing decline.